Dexamethasone in adolescents with post traumatic stress

The main objective of this study is to assess salivary cortisol at baseline and in response to low dose dexamethasone (DST) in adolescents with a diagnosis of Post Traumatic Stress Disorder (PTSD) compared to 1) adolescents with histories of trauma who do not meet diagnostic criteria for PTSD 2) a control group of healthy adolescents from a medical clinic serving the same community.